NATIONAL CHILDREN'S STUDY (NCS)

The National Children's Study has initiated recruitment at 30 study locations around the United States. The Study is the largest long-term study of children's health ever conducted in the United States.